2025 Barrier Function of Mammalian Skin Gordon Research Conference and Gordon Research Seminar

The 17th meeting of the Barrier Function of Mammalian Skin Gordon Research Conference will be held at the Waterville Valley Resort, New Hampshire, USA from August 10-15, 2025. This conference has been held for over 35 years and remains to be the premiere scientific meeting that successfully integrates multiple disciplines and topics focusing on understanding the mechanisms of mammalian skin barrier and its maintenance in health and disease. The function of the mammalian skin barrier is to provide the interface with the external environment and protect the body from dehydration and entry of xenobiotics. As such, its function and maintenance are evolutionarily conserved and guarded by plethora of specific mechanisms. In addition to these biophysical, biochemical and molecular characteristics, the skin barrier presents the key challenge for topical and transdermal drug delivery, including dermatological therapies aiming to restore its function, which altogether brings a unique blend of researchers. The success of the meeting derives from commitment to promoting scientists in early career stages.
The theme of the 2025 GRC is “Technologies and platforms for understanding, modeling and intervening in skin barrier function and disorders.” The overarching objective and long-term goals of this GRC are to present novel discoveries, discuss the latest developments in these fields of expertise through both formal and informal discussions, and to provide a platform for new collaborative opportunities of synergistic team approaches to facilitate future discoveries and novel therapeutic approaches that will advance this multi-disciplinary field. The conference will bring together young investigators as well as prominent leaders to present latest developments in cell biology and pathology, artificial intelligence and machine learning, microbiology, bioengineering, biophysics, physical chemistry, and drug delivery. The 2025 program will consist of nine sessions, eight of which will feature invited speakers presenting new results which will then be followed by a discussion and questions. In addition, each session will include 1-2 short talks selected from submitted abstracts (this approach helps ensure latest breaking scientific updates). In addition to providing insights into the forefront and innovative research developments, this Conference will provide many opportunities for formal and informal discussions – including very dynamic poster sessions throughout the meeting.

Public health relevance
The theme of the 2025 GRC Barrier Function of Mammalian Skin conference is "Technologies and platforms for understanding, modeling and intervening in skin barrier function and disorders”. The skin barrier is the first defense against the external environment (including bacterial infection and absorption of chemicals), and disruption of the barrier plays a key role in many skin and systemic diseases that impact millions of people. This meeting will bring together young investigators as well as prominent leaders to present latest developments in skin barrier research in areas including cell biology and pathology, microbiology, environmental sciences, bioengineering, biophysics, physical chemistry, and drug delivery.